Administrative Supplement for Equipment Purchase

Project Summary
Nuclear RNA processing and surveillance is a complex process involving multiple proteins and protein
assemblies that identify and eventually degrade targeted RNA substrates. The RNA helicase, Mtr4, plays
a central role in this process by providing a bridge between substrate targeting and RNA decay by the
RNA exosome. RNA recognition is performed directly by Mtr4 and by various adaptor proteins that recruit
Mtr4 to targeted substrates. A major challenge is to understand the molecular details of how these
proteins interact with RNA substrates and with each other to achieve substrate specificity. Additionally,
accessory domains within Mtr4 play important but poorly defined roles in substrate recognition and
processing. Notably, the available structural data demonstrate that Mtr4 is a highly dynamic protein, but it
is not known how protein dynamics relate to helicase function. This project seeks to define the molecular
basis for Mtr4 function by employing a variety of biochemical, biophysical and structural approaches,
supported by in vivo genetic analyses. The specific aims of this project are to (1) describe the role of
Mtr4 accessory domains and (2) characterize interactions within the TRAMP (Trf4-Air2-Mtr4) complex.
Undergraduate and graduate researchers with interests in future careers in biomedical research or
medicine will be involved in the project.

Public health relevance
Project Narrative This project addresses fundamental structural and functional aspects of Mtr4 and the Mtr4-mediated complex, TRAMP, that are involved in activation of the eukaryotic exosome. These systems play important roles in controlling the processing and degradation of cellular RNA. Disruption of these RNA surveillance pathways can lead to a variety of disease states, including cancer and neurodegenerative diseases.